Fundamentals of Bioinformatics sandbox module

Project Summary
We propose constructing a module focused on training experimental scientists to interface with
high-dimensional biomedical data generated using a variety of genomics platforms. In our
combined experience training scientists to analyze high-dimensional biomedical data we have
identified three major barriers to experimental biologists accessing, interfacing, and analyzing
biomedical data. First and foremost, is an understanding of what the ‘cloud’ is and how to
access various cloud computing systems. Secondly how to customize a cloud environment with
tools appropriate for an analysis of interest, and finally error mitigation when using new software
to access, manipulate, and analyze digitized biomedical data. Many freely available resources
that introduce the cloud environment are not targeted for experimental biologists, and commonly
lack the practice space and time necessary for some students to grasp foundational concepts
before moving onto the next topic.
Our proposed module uses biomedical data as a training set throughout the module and
focuses on overcoming the three common barriers to learning bioinformatics. Each lesson will
build on the previous lesson to provide a complex and well-rounded understanding of how cloud
environments can be leveraged to interact with digitized biomedical data. Each lesson will begin
with a video and example code, which will then be practiced in the virtual ‘sandbox’
environment, and followed by a self-test activity enabling students to determine if they are ready
for the material in the next lesson. This format enables self-paced learning of foundational topics
that specifically address canonical barriers to working with digitized biomedical data.

Public health relevance
Project Narrative The format of biological data, like most data in the 21st century, has become digitized and is being generated at an exponential pace, interfacing with this data is a challenge for many experimental biologists. We propose to build a module to train scientists to access cloud environments, customize the cloud environment for their analyses, and manipulate digitized biological data.